Evaluation of Treatments and Services to People with Duchenne Muscular Dystrophy

DESCRIPTION (provided by applicant): Project Summary Taken together, Duchenne muscular dystrophy (DMD) and the milder allelic variant Becker muscular dystrophy (BMD) are the most common recessive form of muscular dystrophy. The birth prevalence of DMD has been estimated at 1 in 3,500 (2.9 per 10,000) male births and BMD at 1 in 18,518 (0.5 per 10,000) male births. DBMD are progressive diseases that affect multiple systems including muscular, skeletal, respiratory, and cardiovascular. In addition, social, cognitive and psychological development can be negatively affected by the disease. As a result, a comprehensive, multidisciplinary approach to the care of individuals with DMD is optimal. In order to promote such care, recommendations for treatments and services for individuals with DMD have been developed and include those by the American Academy of Neurology and Child Neurology Society on corticosteroid treatment, American Thoracic Society on respiratory care, American Academy of Pediatrics on cardiac surveillance recommendations and, more recently, the 2010 Care Considerations on whole care developed by panels of experts in the care of DMD and coordinated by the US Centers for Disease Control and Prevention (CDC). Over the past decade, the Muscular Dystrophy Surveillance Tracking and Research Network (MD STARnet) has conducted active, population-based surveillance of DBMD to characterize the epidemiology and develop long-term follow-up and tracking of children with DBMD across four sites in Arizona, Colorado, Iowa, and western New York. For the current project, we propose to utilize and update data collected by the MD STARnet to systematically evaluate agreement between treatments and services provided to individuals who have DMD and compare treatment received to the recommendations documented in the 2010 DMD Care Considerations. This will identify gaps between recommended standards of care and actual care received. Additionally, we will survey health care providers identified by the MD STARnet to identify barriers and challenges involved in the delivery of treatments and services. The geographical area covered by the four sites of the MD STARnet mirrors the socio-demographic characteristics of people with DMD in the United States. Although international efforts to examine the uptake of recommended care in DMD are underway (e.g., TREAT-NMD, Canadian Pediatric Neuromuscular group), similar efforts have not been undertaken in the United States. Our proposed project will allow a comparative evaluation of the implementation of the DMD Care Considerations in a population-based sample of individuals with DMD within the US. This project has the potential of having a major public health impact by evaluating the uptake of care considerations and identifying barriers that may prevent the delivery of recommended health care to individuals with DMD. The dissemination of the findings will inform health care providers dedicated to DMD of the potential disparities between actual and recommended care and provide potential solutions for reducing these discrepancies.

Public health relevance
Project Narrative Anecdotal reports from families indicate that there continue to be differences in treatments and services received by people with Duchenne muscular dystrophy (DMD). Dissemination of project findings will inform health care providers, which deliver services to individual with DMD, about the potential disagreement between actual and recommended care. Barriers to appropriate care will be identified and solutions identified, so that all individuals with DMD will receive the highest level of care no matter where they reside in the U.S. __SpecificAimsTextDelimiter__ Specific Aims Taken together, Duchenne muscular dystrophy (DMD) and the milder allelic variant Becker muscular dystrophy (BMD), are the most common recessive forms of muscular dystrophy. Birth prevalence of DMD has been estimated at 1 in 3,500 (2.9 per 10,000) male births and BMD at 1 in 18,518 (0.5 per 10,000) male births1, 2. Duchenne and Becker muscular dystrophies (DBMD) are progressive diseases that affect multiple systems including muscular, skeletal, respiratory, and cardiovascular. In addition, social, cognitive and psychological development can be negatively affected by the disease. As a result, comprehensive, multidisciplinary approach to care is optimal. In order to promote such care, recommendations for treatments and services for individuals with DMD have been developed and include those by the American Academy of Neurology and Child Neurology Society on corticosteroid treatment3, American Thoracic Society on respiratory care4, American Academy of Pediatrics on cardiac surveillance recommendations and, more recently, the 2010 Care Considerations developed by panels of experts in the care of DMD coordinated by the US Centers for Disease Control and Prevention (CDC)5, 6. Through the 'Muscular Dystrophy Community Assistance, Research and Education Amendments of 2001', the United States House of Representatives and Senate enacted legislation to amend the Public Health Service Act to provide for research with respect to various forms of muscular dystrophy, including DMD. A part of this Act authorized the creation of a National Muscular Dystrophy Epidemiology Program, in which the Secretary, acting through the Director of the Centers for Disease Control and Prevention (CDC), supported national surveillance of DBMD for the purpose of carrying out epidemiological activities, including collecting and analyzing information on the number, incidence, correlates, and symptoms of DBMD. To fulfill this mandate, in 2002, the CDC awarded four sites - Arizona, Colorado, Iowa and New York - cooperative agreements (RFA 02172) to develop a surveillance network, the Muscular Dystrophy Surveillance Tracking and Research Network (MD STARnet). The overall objective of MD STARnet was to: 1) conduct active, population-based surveillance of DBMD to characterize the epidemiology of DBMD and its complications and 2) develop long-term follow-up and tracking of children with DBMD. For the current project, we propose to utilize and update the data collected by the MD STARnet to systematically evaluate agreement between treatments and services actually provided to people who have DMD and compare treatment received to the recommendations documented in the 2010 DMD Care Considerations. This will identify gaps between the recommended standards of care and actual care received. Additionally, we will survey health care providers within the MD STARnet sites to identify barriers and challenges involved in the delivery of treatments and services. Aim 1. Collect Data on Treatments and Services Delivered to Individuals with DMD Data collected from the active, population-based surveillance activities of the MD STARnet will be used to document treatments and services delivered to individuals with DMD. The follow-up abstraction of medical records of individuals identified by the MD STARnet will provide three years of data (2011-2013) since the publication of the care considerations to evaluate changes in clinical practice management. Aim 2. Administer Survey to Health Care Providers Providing Care to Individuals with DMD A survey targeting health care providers identified by the MD STARnet will be developed. The survey will be modeled after existing surveys created by CARE NMD and the Canadian Pediatric Neuromuscular Group to allow global comparisons of DMD care. Aim 3. Evaluate Agreement between Actual Treatment and the DMD Care Considerations We will develop performance indicators and use statistical benchmarks of the DMD Care Considerations to evaluate agreement between actual and recommended treatment. In addition, the Health Care Provider survey will include questions about barriers to the provision of recommended care. From these responses, we will develop strategies to reduce barriers to care and determine the need to revise and/or expand the recommendations to meet the needs of individuals with DMD. Aim 4. Translation of Findings and Final Report The MD STARnet consists of expert clinicians, statisticians, and epidemiologists. We will rely on this network of experts to disseminate findings through peer-review journals and collaborations with parent advocacy organizations to distribute findings to caregivers of individuals with DMD. A final report summarizing the work of the MD STARnet will be delivered to the CDC and other partners involved in the care of individuals with DMD.